Visium spatial transcriptome analysis add on to the current proposed scRNA seq analysis

ABSTRACT:
This application is being submitted in response to the Notice of Special Interest (NOSI) identified
as NOT-CA-23-045.
Cisplatin induced Acute kidney injury (C-AKI) is a complex condition with significant morbidity and
mortality. Our research team aims to investigate the cellular and molecular mechanisms involved
in AKI and therapy response. We have used single-cell RNA sequencing (scRNA seq) to
investigate gene expression levels in individual cells. However, scRNA seq lacks spatial context,
which is important for understanding cell-cell interactions and the microenvironment. Therefore,
we propose adding Visium Spatial Transcriptomics, a cutting-edge technique that combines
histological imaging with RNA sequencing, to our study. We aim to analyze gene expression
levels in a spatially resolved manner, identify new cell types and their spatial distribution, and
generate high-resolution maps of gene expression patterns in kidney tissue. To investigate the
spatial expression patterns of genes involved in the immune response and other processes
affected by APE2-ASO treatment, we propose a study using Visium Spatial Transcriptomics in
the APE2 ASO-treated cisplatin-induced AKI model. By adding Visium Spatial Transcriptomics to
our ongoing AKI study, we aim to gain a deeper understanding of the cellular and molecular
mechanisms involved and identify potential therapeutic targets.